G0S2 in chronic myeloid leukemia disease progression and imatinib resistance

PROJECT SUMMARY/ABSTRACT Chronic myeloid leukemia (CML) is caused by BCR-ABL1, a constitutively active tyrosine kinase. The development of tyrosine kinase inhibitors (TKIs) targeting BCR-ABL1 has revolutionized the treatment of CML, turning it from a fatal into a manageable chronic condition. Many patients respond favorably to TKIs, but some patients do not achieve a response, and others lose their response, for an overall estimated failure rate of 20- 30% in chronic phase (CP-CML), and even higher rates in advanced CML. While TKI resistance is commonly linked to point mutations in the BCR-ABL1 kinase domain, ~50% of clinical resistance cannot be explained by BCR-ABL1 mutations, suggesting BCR-ABL1 kinase-independent resistance. Recurrence of active CML after discontinuation of TKIs in responding patients is thought to reflect persistence of quiescent leukemic stem cells (LSCs) that are innately resistant to TKIs despite BCR-ABL1 inhibition. Thus, understanding the molecular mechanisms underlying BCR-ABL1 kinase-independent resistance will be critical to identify alternative treatment strategies for patients with TKI resistance or advanced CML and to eradicate disease. Microarray data revealed downregulation of G0S2 mRNA expression in CML CD34+ cells from imatinib non-responders (without mutations) compared to responders, and in advanced disease compared to chronic phase. Preliminary data suggests that G0S2 may play a role in both primary TKI resistance and in blastic transformation of CML. Specific Aim 1: Determine whether G0S2 loss promotes TKI resistance and disease progression in CML. Data from this aim will investigate the functional consequence of G0S2 loss in TKI resistance and blastic transformation. We will assess the role of G0S2 in the growth, survival, and TKI sensitivity of CML cell lines and primary CML CD34+ cells both in vitro and in vivo. We will also utilize a BCR-ABL1 transgenic mouse model and G0S2 null mice to assess the role of G0S2 in CML leukemogenesis in vivo. Specific Aim 2: Identify the mechanism by which loss of G0S2 induces TKI resistance in CML. G0S2 has been implicated in metabolic pathway regulation, including fatty acid synthesis and oxidative phosphorylation. We have formed a collaborative research team to rigorously establish the mechanistic role of G0S2 downregulation in TKI resistance. We will address how reduced expression of G0S2 influences these metabolic pathways and, in turn, whether these pathways alter imatinib response. Specific Aim 3: Determine the mechanism(s) by which G0S2 is downregulated in TKI resistance and identify strategies to restore G0S2 expression. Data from this aim will identify how G0S2 is downregulated in TKI resistance and blastic transformation, and will identify ways of reprogramming TKI-resistant cells into a TKI-sensitive phenotype. We will investigate the potential role of promoter hypermethylation and binding of transcriptional repressors, as well as the contribution of known oncogenic signaling pathways. These studies will be crucial for developing novel treatment approaches for TKI- resistant CML patients and other drug-resistant leukemias, and will launch my independent research career.

Public health relevance
OTHER PROJECT INFORMATION Description of Disruptions Per NOT-OD-21-052, “Requesting Extensions for Early Career Scientists Whose Career Trajectories Have Been Significantly Impacted by COVID-19,” I respectfully request an additional 6 months funded extension for award number K22CA216008. If approved, the new ending date will be February 28, 2022. Currently, our unobligated balance is approximately $20,409 ($18,897 of direct costs; $1,512 of indirect costs). My career development activities have been significantly impacted above and beyond lost research productivity that most researchers experienced due to coronavirus disease 2019 (COVID-19)-related shutdowns. Funds requested in the budget extension will cover the cost of completing experiments that were not completed as a direct result of institutional closures resulting from the COVID-19 pandemic. Additional time will allow me as PI to complete experiments placed on hold, particularly in vivo experiments with G0S2 knockout mice (as outlined in Aim 1), as well as the required metabolic data (as outlined in Aim 2). Additional time will also allow me to complete the Responsible Conduct of Research training as required by the K22 award agreement. Texas Tech University Health Sciences Center at El Paso (TTUHSC El Paso) operated under Phase IV (Closed Campus) from March 16th, 2020 through May 31st, 2020, during when on-campus operations were restricted only to critical functions (e.g. clinical services). All laboratory personnel worked virtually from home during this time, and access to my lab was not allowed. This lockdown paused many experiments that were critical to finishing the project, entitled “G0S2 in chronic myeloid leukemia disease progression and imatinib resistance.” The following is a list of the challenges that were faced for this project: 1) Lost research productivity: Not being able to perform the initially scheduled experiments prevented submission of an R01 during year 2 of the award period, as required by the NCI. This could have long- term implications for the K-to-R transition and my tenure and promotion. 2) Severe reduction of animals critical for experiments: We euthanized a large number of experimental animals (n=78) in preparation for the lockdown. We have not been able to breed our G0S2 knockout mice back to numbers that would be required for the funded experiments. We expect to have enough mice for bone marrow transduction and transplantation experiments by August of 2021, which is currently the last month of the award. 3) Social distancing requirements: Adherence to CDC social distancing guidelines reduced the number of personnel who could physically be in the lab at any given time, further contributing to a reduction of research productivity. 4) Parental responsibilities: As the mother of 6 and 9 year old children, I faced many additional challenges both during the 2.5 month lockdown (2 children at home full-time with 2 full-time working parents), and after the lockdown (5 additional months of virtual learning to manage for both children). Additionally, as the woman of the house, I took on a disproportionate burden of household and dependent care responsibilities, further limiting productivity on research and career development activities. 5) Paused career development activities: Due to university closures, remote working schedules, and modifications of courses for online distribution, I was not been able to fulfill the requirement for Responsible Conduct of Research training, and will need additional time for completion. While the TTUHSC El Paso Phase IV shut-down only lasted for 2.5 months, I am requesting a total of 6 months of additional funding to cover challenges that went above and beyond lost research productivity. Should you have any questions, please do not hesitate to contact me or my Research Administrator, Ms. Maria Hernandez, using the contact information included below or in the email. Thank you for your time and consideration of this request.